Clinical Translation and Validation Core

The Johns Hopkins University (JHU) Artificial Intelligence (Al) and Technology Collaboratory (AITC) proposes
a Clinical Translation and Validation Core that aims to cultivate and support cutting edge Al prototype testing
and exploratory studies that are needed to develop crucial larger scale and confirmatory pilots in order to
advance the development of effective Al technologies to facilitate independence in older adults. This core is
designed to serve as a hub and a clinical laboratory for innovators to validate prototypes and undertake
rigorous feasibility testing for the Al algorithms and technology devices in clinical and "real-world" settings. The
specific aims of the Clinical Translation and Validation Core are 1) To provide state-of-the-art scientific (Clinical
and Engineering) expertise and work with the administrative core to facilitate soliciting proposals and
identifying and selecting Al approaches or technologies to be clinically validated in the Collaboratory or our
partner sites; 2) To develop and maintain a research registry with emerging Al approaches or technologies to
be validated in clinics and identify clinical researchers (and their clinical studies) and other stakeholders
interested in validating Al algorithms or technologies in their clinics or other real-world settings; 3) To provide
the AITC investigators identified in aim 1, with mentorship and training in all aspects of human subjects'
research, including study conceptualization, study design and outcomes, definition of interventions,
measurement, data analysis, protocol development and implementation, regulatory approval, quality
assessment, and standard operating procedures related to aging, dementia and the maintenance of
independence; 4) to provide intellectual leadership necessary to identify and match Al researchers with clinical
research investigators that are best suited to successfully validate prototypes and undertake rigorous feasibility
testing for the artificial intelligence algorithms and technology devices in both clinical and "real-world" settings;
and 5) to facilitate the transition of successful prototypes into clinical studies in collaboration with the
leadership of the Pilot Cores (Aging and AD) as well as all other cores. To achieve these goals, the core is led
by an Al and technology development experienced investigator partnered with a Geriatrics Clinician Scientist
with expertise in translational research focused on physical and cognitive decline in older adults. This balanced
leadership will facilitate the development, implementation, and conduct of prototype development and testing in
this core. A highly skilled and experienced research program manager with expertise in minority recruitment
and the measurement of frailty and mobility will facilitate the completion of these aims. These aims will be
carried out in collaboration with the leaders of all other cores. Additional resources are provided by the JHU
Institute of Clinical and Translational Research, which will help to ensure optimal study design, implementation,
measurement, and interpretation of results, and Fast Forward, a translationally-focused unit at JHU, will
facilitate health technology development that focuses on using Al to maximize independence in older adults.